South Texas Alzheimer’s Disease Center Outreach, Recruitment and Engagement Core

Summary Outreach, Recruitment and engagement (OREC)
In 2050, Hispanic adults over age 65 are expected to account for 20% of the population, up from
7% in 20101. However, they remain underrepresented in research2,3. The situation is even more
critical since Hispanics are disproportionately affected by Alzheimer´s disease (AD). As the
community facing entity of the South Texas Alzheimer´s Disease Center (STAC), the Outreach,
Recruitment and Engagement Core (OREC) will support inclusive, engaged and sustained
participation of diverse older adult populations and their caregivers in South Texas as research
participants in social, behavioral, and biomedical research including clinical trials. Furthermore,
the OREC will strengthen current infrastructure to disseminate and translate research advances
that can impact the engaged communities –local and lay- and has an active mechanism to
obtain community feedback on its services and research, to establish true bi-directional
communication. The specific aims of the OREC are (1) systematically assess community
priorities, needs, barriers to, and interests in AD and related disorders (ADRD) research in
South Texas through conduct of open-ended focus groups, in-depth interviews, and surveys (2)
expand capacity for community-academic partnerships that will support the recruitment and
retention of older urban and rural Hispanics and their families in South Texas and in particular
along the US/Mexico border through a) receiving advice and input from a Community Advisory
Board (CAB) b) providing technical assistance and training to key STAC members in other
cores and c) providing technical assistance and training to key STAC members in other core; (3)
work collaboratively with the other STAC cores to recruit, engage and retain participants; and
(4) disseminate research findings to the scientific community, health care providers and the
communities we serve in South Texas, particularly to elderly and their caregivers. We will
achieve these aims through an integrated program to promote a deep understanding of the
determinants of participation and engagement of diverse and underserved populations of South
Texas and creating and maximizing channels for engagement and community training to
facilitate the adoption of best practices promoting participation in research studies. We will
create a state-of-the art infrastructure for researchers, health care providers, advocates and
policy makers interested in decreasing health disparities affecting older Hispanics affected by
ADRD. To accomplish these goals, we have built a team of scientists with extensive experience
in community change, community–based research, education, recruitment and retention of
Hispanic populations, from two institutions within the University of Texas (UT) system, UT
Health San Antonio and the UT Rio Grande Valley. By integrating and leveraging resources, we
will create a welcoming study environment and through our partnerships and direct access to
health agencies, health care providers, clinicians and community-based organizations of South
Texas we are uniquely positioned to maximize recruitment, assessment and retention of
Hispanics, a group that is underrepresented in ADRD studies.